The role of cerebrospinal fluid complement activation in delirium and post-intensive care unit long-term cognitive impairment

PROJECT SUMMARY/ABSTRACT
This K23 application outlines a career development plan that will advance Dr. Michael Devinney on his pathway
to becoming an extramurally funded, independent critical care physician-scientist. His long-term career goal is
to discover underlying mechanisms that contribute to delirium and its sequelae such as post-ICU cognitive
impairment and Alzheimer's Disease and related Dementias (ADRD).
Delirium is a syndrome of disrupted attention and consciousness that occurs in ~20% of the >19 million older
surgery patients and ~50% of the >5 million intensive care unit (ICU) patients in America every year. Delirium is
also associated with increased risk for long-term cognitive impairment and ADRD, yet there are no FDA-
approved drugs to prevent delirium, due to a major gap in our understanding of the mechanisms that drive
delirium. One possible mechanism that may underpin delirium (and subsequent post-ICU long-term cognitive
impairment) is neuroinflammation. Surgical trauma and critical illness induce systemic complement activation
and blood-brain barrier dysfunction, which could cause activated complement factors to enter the brain. These
activated complement proteins then can cause synaptic tagging for phagocytosis, which can disrupt the neural
connectivity necessary for human cognition. Indeed, complement-dependent synapse loss leads to memory
deficits in mouse ADRD models, and patients with ADRD have increased cerebrospinal fluid (CSF) C3 levels.
However, few, if any, studies have investigated the role of CSF complement activation in delirium and post-ICU
long-term cognitive impairment. In this proposal, Dr. Devinney will determine the role of CSF complement
activation in postoperative delirium, ICU delirium, and post-ICU long-term cognitive impairment. To do so, he will
leverage a unique perioperative CSF biorepository, and also recruit a prospective cohort of 120 older ICU
patients that will undergo CSF sampling, delirium assessments, and 6-month post-discharge cognitive testing
and dementia assessments. CSF complement activation will be measured with immunoassays, and unbiased
proteomics will be used to characterize CSF complement levels and to discover other novel pathways involved
in these disorders. CSF ADRD biomarkers will also be measured in both cohorts.
Dr. Devinney has co-designed a career development plan and a research proposal with his cross-disciplinary
mentorship team to accomplish the following short-term objectives: 1) Obtain expertise in the molecular role of
complement in synaptic dysfunction and ADRD 2) Develop a thorough understanding of the practical and ethical
considerations of ICU research, 3) Acquire the skills needed to lead larger studies of older ICU patients, and 4)
Gain expertise in the staging of ADRD. These objectives will be accomplished through formal training,
workshops, experiential learning, and focused mentorship. Thus, this K23 award will allow Dr. Devinney to
acquire the outlined research skills, knowledge, and experience to continue his pathway towards independence.

Public health relevance
PROJECT NARRATIVE Delirium is a type of acute confusion experienced frequently by older adults after surgery or during critical illness that is associated with subsequent long-term cognitive impairment and increased risk for Alzheimer's Disease and Related Dementia. Yet, we currently lack drugs to prevent delirium due to a poor understanding of its underlying biological mechanisms. Using immunoassays and unbiased proteomics of cerebrospinal fluid obtained from older surgical and critically ill patients, the current study aims to test whether increased levels of activated complement proteins, a set of powerful inflammatory mediators, are associated with 1) postoperative delirium, 2) intensive care unit (ICU) delirium, and 3) post-ICU long-term cognitive impairment.